PROTECTION FROM VIRAL GASTROENTERITIS BY INTESTINAL CTLS

Infections of the intestinal tract are among the most prevalent causes of disease and death worldwide. In Asia, Africa and Latin America, between 1978 and 1979, 3 to 5 billion cases of diarrhea accounted for 5 to 10 million deaths. The devastating impact of these pathogens has excited interest in host immunity at the intestinal mucosal surface. Much of this interest has focused on the importance of secretory lgA. However, the role of intestinal T lymphocytes in intestinal infections has not been explored. Considering that a sizable portion of the host's total number of T cells is contained in the intestine, little known about the trafficking, memory, or function of these cells after enteric infection. We will examine the importance of intestinal cytotoxic T lymphocytes (CTLs) in protection against enteric infection. Infection of mice with a common intestinal pathogen, rotavirus, will be used to determine 1) the capacity of intestinal and nonintestinal CTLs to protect against rotavirus gastroenteritis, 2) the function, trafficking and memory of rotavirus-specific intestinal and nonintestinal CTLs and CTL precursor after enteric infection, 3) the rotavirus antigens recognized by serotype- specific and crossreactive CTLs, and 4) the T cell receptor proteins which mediate rotavirus-specific CTL activity. We recently found that rotavirus-specific CTLs appear at the intestinal surface after enteric infection. In addition, adoptively-transferred rotavirus-specific Thy1+ CD8+ lymphocytes protect suckling mice against challenge. Rotaviruses are an excellent pathogen for the study of intestinal immunity. First, rotaviruses are the most common cause of infant and childhood gastroenteritis both in the United States and in developing countries. Second, murine rotaviruses, similar to human rotaviruses, replicate in intestinal epithelial cells and are a virulent, natural host pathogen; the pattern of viral replication, diarrhea, and spread found in mice after oral inoculation mimics that found in human disease. Third, we have recently adapted 2 murine rotavirus strains (representing two serotypes) to growth and plaquing in tissue culture. Adaptation of murine rotaviruses to growth in tissue culture allows for an accurate determination of the virus dose used for in vitro and in vivo studies.